Aging lymphocytes: senescence programs in lymphocytes relevant to human inflammatory bowel disease

PROJECT SUMMARY/ABSTRACT
FOXP3+ CD4+ cells are expanded within the inflamed mucosa of Crohn’s disease (CD) patients; yet the
persistence of intestinal inflammation suggests these CD associated CD4+FOXP3+ cells lack typical regulatory
T cell (TREG) suppressive function. The functional and therapeutic implications of senescence in FOXP3+ TREG
cells is unknown. The long-term goal of this application is to dissect the epigenetic mechanisms driving the
differentiation and function of CD4+FOXP3+ cells in the setting of intestinal inflammation. Consequently, the
overall objective of this proposal is to identify the mechanisms leading to senescent FOXP3+ cells in the setting
of GI inflammation and test therapeutic opportunities to restore regulatory function. The central hypothesis is that
CD associated FOXP3+ cells represent a senescent state and contribute to intestinal inflammation. Furthermore,
this new cellular phenotype (senescent FOXP3+ cell, snFOXP3) represents a potential therapeutic target. This
hypothesis was formulated through single cell transcriptomic analysis of CD4+FOXP3+ cells from the lamina
propria of CD patients, produced by this applicant’s laboratory. The rationale is that defining the mechanisms
critical to the development and function of snFOXP3 cells in the setting of inflammation will uncover targets for
TREG-directed therapies, including the advanced engineering of human TREGS for adoptive cell therapy trials.
Guided by strong preliminary data, this hypothesis will be tested by pursuing three specific aims: 1) Why do
FOXP3+ cells become senescent in the absence of BMI1?; 2) Why are FOXP3+ cells senescent in Crohn’s
disease?; and 3) Why are snFOXP3 cells proinflammatory? Under the first aim, the applicant will utilize
epigenetic assays, which have been established as feasible in the applicant’s hands, to establish BMI1
repression on an ETS1-regulated senescence program in FOXP3+ cells. Antibodies and assay reagents that
are already on hand will be used. Under the second aim, the applicant will utilize a biochemistry approach with
treatment of cultured TREGS to determine a TNFα-induced disruption of BMI1-mediated repression of
senescence. Finally, under the third aim, the applicant will use a novel in vitro co-culture system to establish the
proinflammatory capacity of snFOXP3 cells and establish therapeutic targets. The approach is innovative
because it departs from the status quo of functional characterization of CD4+FOXP3+ cells utilizing single cell
approaches, and a mechanistic approach to define the epigenetic events that lead to a pathogenic snFOXP3
cell. Upon conclusion, the applicant will understand the epigenetic mechanisms leading to the development of
snFOXP3 cells in the setting of intestinal inflammation. This contribution is significant as the snFOXP3 is
expanded in the Crohn’s lesion, is proinflammatory, and represents an important epigenetic drug target. This
project is the first to articulate both signature and precise epigenetic events that regulate activation of senescence
in TREGS in intestinal inflammation, therefore advancing the field of therapeutics in engineered cell therapies in
the setting of autoimmune diseases.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of the underlying mechanisms leading to the development of senescent FOXP3+ cells in inflammation will open novel experimental therapeutics, including cellular therapy in human Inflammatory Bowel Disease (IBD) and other immune- mediated diseases (i.e., rheumatologic, neurologic, dermatologic conditions, and cancer). Insight into the development of senescent FOXP3+ cells will benefit TREG cell therapy trials, as well as trials of epigenetic regulators in cancer research. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to developing fundamental knowledge to reduce human illness.